Community Health Worker Navigation to Support Mental Health

Project Title: Community Health Worker Navigation to Support Mental Health
This community health worker navigation intervention is led by the CANA neighborhood-based organization in San Francisco’s Mission District in collaboration with government and local partners. This intervention aims to test community health worker support and protocolized navigation to mental health services and wellness activities vs. wellness activities alone (treatment as usual). These efforts are a clear continuation and extension of CANA’s work and mission, critical for mental health (e.g., depression and anxiety and well-being of individuals and families. Central to this collaborative plan is a mixed methods approach with local organizations that together form the CAPAZ Hub. This work is in collaboration with professional health services researchers at UC Riverside, whose goal together is to identify and address factors that impact mental health outcomes.

Public health relevance
The proposed work will contribute to scientific understanding of mental health distress and stress-related disorders, including modifiable factors that support improved outcomes. Deliverables will include replicable and generalizable materials, protocols, and implementation processes that can be adopted by health, education, and community service systems to strengthen population-level mental health promotion and prevention efforts